Understanding the Metabolic Regulation of Immune Responses to Bacterial Infections

Project Summary/Abstract:
My research program investigates how the host metabolism impacts immune responses during infection. While
immune evasion strategies by bacterial virulence factors are well recognized, especially during the initiation of
infection, the mechanisms by which immune responses are modulated to promote disease tolerance and
pathogen persistence are less well understood. Numerous studies have shown that metabolic activities govern
the function of immune cells, an emerging field called immunometabolism. Notably, upon stimulation with
bacterial components, immune cells typically upregulate glycolysis to fuel inflammation and promote bacterial
clearance. However, we and others have recently shown that live bacterial pathogens can manipulate the
canonical glycolysis-induced inflammatory signaling to promote persistent infections.
Within the next five years, we aim to deepen our mechanistic understanding of how host metabolic activities
influence immune cell activation and function. Importantly, we will dissect the metabolic pathways that favor
immune suppression versus activation using dietary and pharmacological interventions in our infection models.
Such approaches could provide a new framework for treating a range of pathogens at diverse sites of infection,
potentially transforming infection control strategies. In addition, the knowledge generated may have broader
applications in inflammatory pathologies or metabolic disorders. Our research will be conducted through a
multidisciplinary approach, incorporating advanced omics technologies such as next-generation transcriptomics,
metabolomics, spatial metabolite imaging and indirect calorimetry, to achieve our objectives.

Public health relevance
Project Narrative: This project will examine the metabolic basis of immunity using bacterial infection as a model system, specifically exploring how the host metabolism influences immune cell activation and function. By applying dietary and pharmacological interventions to alter the host metabolism, we aim to further increase our understanding of the metabolic pathways that facilitate disease tolerance versus effective immune clearance. This knowledge will lay the foundation for the future development of host-directed strategies to clear diverse pathogens across various infection sites and may have broader implications in metabolic and inflammatory disorders.